Modeling and characterizing early ALK-dependent lung tumorigenesis

PROJECT SUMMARY
Lung cancer in never-smokers comprises up to a quarter of lung adenocarcinomas. One of the most frequent
subtypes of LCINS is caused by chromosomal rearrangements leading to activation of Anaplastic Lymphoma
Kinase (ALK). Early detection of ALK+ cancer is not possible, and it is usually diagnosed at the metastatic
stage. This proposal combines several unique and complementary resources and approaches, including
patient samples, primary stem cell cultures, mouse modeling, and single cell technologies, to address the
critical need to identify and understand the early cellular and molecular changes that occur upon ALK
activation. Aim 1 will develop a single cell atlas of ALK+ lung cancer by profiling patient samples and
examine the effect of ALK on plasticity in engineered lung organoids. Aim 2 will test the functional relevance
of the redox-buffering transcription factor NRF2 in ALK+ lung cancer initiation. Together the aims presented in
this proposal will provide the first molecular characterization of early ALK+ lung cancer and provide a
foundation for the development of novel diagnostic and therapeutic strategies for this devastating disease.
Dr. Peggy Hsu, MD, PhD is a physician-scientist performing mentored research in the laboratory of Dr. Jason
Spence and is co-mentored by Dr. Sofia Merajver. Her long-term goal is to be an extramurally funded
research program that aims to understand the principles of cell fate determination and its dysregulation in lung
cancer. During the K08 training period, Dr. Hsu will acquire additional scientific training and develop skills
required for managing an independent laboratory. She will spend at least 75% of her time engaged in the
proposed research with the rest of her effort spent taking care of patients with cancer. Dr. Spence is an expert
in lung developmental biology and organoid modeling, Dr. Merajver is a leader in translational oncology, and
Dr. Hsu will be guided by an exceptional Scientific Advisory and Career Development committee. With an
exemplary institutional environment and commitment, training plan, program, mentorship, and proposed
research, this K08 award will enable Dr. Hsu to conduct groundbreaking research and transition to
independence.

Public health relevance
PROJECT NARRATIVE ALK-positive lung cancer is typically diagnosed at an advanced and incurable stage. Almost exclusively afflicting patients with no smoking history, we do not know how it arises. This project uses patient samples, stem cell organoid cultures, and mouse models to characterize the earliest events in ALK-positive lung cancer with the hope that our findings will lead to improved diagnostic tests or treatments for this devastating disease.